Impact of Obesity on Brain Immune Response and Cognition

Midlife obesity is associated with earlier onset of Alzheimer’s disease (AD) and increased AD neuropathology.
Diets high in the saturated fatty acid palmitic acid (PA; C16:0) are a major contributor to obesity. They also
potentiate neuroinflammatory diseases and exposure to dietary saturated fatty acids prime microglia (brain
immune cells) towards an inflammatory phenotype. Because neuroinflammation and microglial activation are
factors implicated in the etiology of AD we hypothesize that proinflammatory priming of brain microglia
exacerbates AD pathology and increases accumulation of amyloid beta (Aβ) plaques characteristic of AD. If
confirmed, this biological model could elucidate targets for primary and secondary prevention of AD. For the
current study we propose use of a high-saturated fat diet to trigger a proinflammatory state in transgenic mouse
models of AD, and to test whether stimulation of microglial proinflammatory pathways contributes to AD
pathogenesis and progression. Microglia are key mediators of neuroinflammation and directly link diet with brain
health. In the brain the fatty acid binding protein 4-uncoupling protein-2 (FABP4-UCP2) axis mediates
proinflammatory effects of saturated fatty acids. Modification of the FABP4-UCP2 axis is a potential mechanism
by which high fat diet exacerbates neuroinflammation and AD pathology.
We hypothesize that proinflammatory priming by high fat diet in brain microglia exacerbates AD pathology and
increases accumulation of amyloid beta (Aβ). The overall objective is to test the pathogenic role of the FABP4-
UCP2 axis in AD in presence and absence of a proinflammatory trigger (high-fat diet). To provide a mechanistic
understanding of how the FABP4-UCP2 axis perturbs microglial metabolic adaptation and exacerbates AD, we
propose the following We propose the following Specific Aims to test our hypothesis: Aim 1) Determine the role
of HFD and FABP4 on AD pathology in mouse models of Alzheimer’s (APPswe/PS1ΔE9 and
APPswe/PS1ΔE9/FABP4flox/Tmem119CreERT2); and Aim 2) Determine biochemical and pharmacological effects
of HFD and FABP4 on neuroinflammation in mouse models of AD. We will evaluate the role of the microglial
FABP4-UCP2 axis in exacerbation of AD pathology. This targeted approach investigating diet-induced cognitive
impairment will identify pathways and clinical targets for treatment of chronic proinflammatory diseases such as
metabolic syndrome that increase the risk of AD.
Significance to Veterans Health Care: Our approach is novel in that it will use a transdisciplinary approach
(nutritional biochemistry neuroscience and pharmacology) to define interactions of diet in aging, metabolic
disease, neuroinflammation, and AD. As underserved populations are at higher risk for developing obesity and
AD, the broader long-term impact of this work is that our experiments will lead to better treatment options for at
risk communities.

Public health relevance
Obesity and associated comorbidities such as metabolic syndrome and diabetes affect up to 48% of Veterans, and are known risk factors for cognitive impairment and development of Alzheimer’s disease. The incidence of these neurodegenerative diseases may be higher in Veterans than in the general population. Our work supports that the onset of brain immune response (neuroinflammation) represents a link between obesity and cognitive impairment. Dietary metabolites such as fatty acids affect lipid metabolism in brain immune cells (microglia), resulting in a state change to a toxic inflammatory microglial phenotype. We hypothesize that obesity alters microglial function to directly trigger dysregulated brain immune responses and neuronal cell death, resulting in impaired cognition and altered brain circuitry. Our short term goal is to characterize regulatory changes that promote neuroinflammation and subsequent cognitive decline. Our long-term goal is to leverage this knowledge to develop targeted therapies to treat cognitive impairment and neurodegenerative disease.